VCU NIGMS Mentoring supplement

Developing Coaching Skills for Mentors: Summary
Virginia Commonwealth University (VCU) has a demonstrated commitment to training students from diverse
and underrepresented backgrounds. This commitment is reflected across training programs within VCU
including the portfolio of NIGMS-funded training awards. Critical to training individuals of all backgrounds is
empowerment. Using coaching skills in mentoring interactions builds independence and confidence and has
been demonstrated to increase retention of junior faculty from underrepresented backgrounds. Similar reports
for increased retention and achievement have been documented when coaching models are applied in
undergraduate medical education. Further, reports that coaching can decrease burnout and increase progress
to independence, highlight key benefits of adding coaching skills to the tools available to VCU’s mentors.
Mentor trainings and activities currently in place at VCU focus on many essential skills including cultural
awareness, the need to build independence, clear communication, and transparency; however, there are no
existing resources accessible to our mentors that teach and develop coaching skills. The development and
refinement of coaching skills will provide a new skill set for mentoring trainees. Given the multi-faceted training
roles and departmental affiliations of our mentors, the impact of the proposed pilot program will cut across
programs, departments, and schools at VCU. In addition, to ensure impact across the university, faculty
recruitment to the Coaching Skills for Mentors program will be deployed across actively funded NIGMS training
award programs at VCU. We propose to enhance the mentoring relationships within our NIGMS-funded
training programs at VCU through training 20 active mentors in the FUEL coaching model and providing
ongoing support through the year of the supplement funding to promote incorporation and proficiency of this
new skill set. The FUEL model is a defined framework for coaching-based interactions that begins with
Framing the conversation, followed by Understanding the current state, Exploring the desired state, and Laying
out a success plan. Although some efforts have already been initiated for using coaching models in biomedical
training, these have been more aligned with advice-giving than coaching. In addition, published reports of
previous efforts to use coaching in academic settings note that a clear framework was not provided, which
limited coaching confidence. By teaching our mentors the FUEL model and providing ongoing support
throughout the year, the probability of success will be bolstered. By the end of the program, mentors will be
equipped to influence elevated learning and performance of trainees through transformational coaching skills.

Public health relevance
Developing Coaching Skills for Mentors: Narrative Mentoring is critical to the development of a diverse biomedical workforce. Current training programs for mentoring skills do not include development of coaching skills for mentors. The pilot program proposed in this NIGMS training grant supplement adapts an existing curriculum for training managers in coaching skills to develop coaching skills in biomedical research mentors with a year of skill refinement and support.